Research Training in Pediatric Emergency Medicine

Project Summary/Abstract
The Pediatric Emergency Medicine Research Training Program (PEMRTP), established in 2001, offers unique
multi-disciplinary training for MD and PhD biomedical researchers to acquire necessary skills for investigating
the acute illnesses and injuries that form the clinical basis of the subspecialty of pediatric emergency medicine.
In the United States, between 19 and 25 million children make more than 29 million emergency department
(ED) visits each year. Eighteen percent of children have at least one ED visit annually. About 4% of these visits
result in hospitalizations. The total annual cost of ED care is almost $50 billion and 20% of visits are for
children. When arriving at the ED, a parent can think of nothing more important than that their acutely ill or
injured child receive the best, evidence-based care with the most effective diagnostics and treatments.
Pediatric research makes this possible. The NIH recognizes the importance of emergency medicine research
and has recently designated a trans-NIH Office of Emergency Care Research to foster basic, translational, and
clinical research and training for the emergency setting. This T32 competing renewal leverages the assets of
Boston Children’s Hospital Emergency Department, which includes the largest pediatric emergency medicine
faculty, and leading informatics programs at Harvard. PEMRTP draws on core strengths to create a culture of
rigorous research and research training to (1) prepare individual trainees as independent researchers, (2) fill
the critical need for early and mid-career research mentors for the next generation of pediatric emergency
medicine trainees here and elsewhere, and (3) bolster pediatric emergency medicine research with biomedical
informatics and genomics. Trainees progress toward independence in three interrelated phases: (1) a
mentored research project, (2) formal course work, and (3) preparation of a research grant. Trainees complete
either a Master of Medical Science or Master of Public Health degree. They are mentored in their laboratory of
choice. And finally, with guidance from a faculty mentor, they prepare a K99/R00 or similar mentored research
grant application to facilitate their transition to independent faculty. Boston Children’s Hospital and Harvard
Medical School, by the breadth and depth of their research laboratories, operational, real-world clinical
systems, formal academic programs, experienced faculty, and linkages to multisite research networks, provide
an unparalleled environment for mentoring trainees to become future leaders. PEMRTP specifically builds on
the international reputation of Boston Children’s Hospital in biomedical informatics and genomics and seeks to
train its fellows to use tools from these fields to exploit the pediatric ED as a laboratory for clinical, translational
and population research.

Public health relevance
Project Narrative In the United States, 19 to 25 million children make more than 29 million emergency department (ED) visits each year. The Pediatric Emergency Medicine Training Program offers unique training in biomedical informatics and genomics for the next generation of leaders in pediatric acute care research. Thus, when ill or injured children arrive at the ED, they can receive the best evidence-based care, with the most effective diagnostics and treatments possible.